Advanced Research Training in Transplantation Science

Abstract
This competitive renewal seeks funding for years 16-20 of a successful institutional training grant focusing on
the science of organ and tissue transplantation. The Advanced Research Training in Transplantation Sciences
(ARTTS) program at Emory University serves an area of medical science-- transplantation biology-- that is
exceptionally rigorous, uniquely multidisciplinary, and in dire need of new students to take up the substantial
momentum established in the past 30 years. The application seeks to fund 1 pre-doctoral and 2 post-doctoral
trainees each year, and individual appointments will last for 2 years. It seeks to produce trainees that go on to
establish independent research programs in the area of transplantation biology. Since its inception in 2006, the
program has successfully recruited and trained 9 pre-doctoral trainees and 14 post-doctoral trainees. Of the 6
pre-doctoral ARTTS trainees who have completed training, 100% had a first author publication as a result of
their graduate research, and on average they published an impressive 4.4 first author and 6.0 total peer-
reviewed manuscripts. Of the 12 past post-doctoral ARTTS trainees who have completed training, 100% had a
first author publication as a result of their post-doctoral research, and on average they published 2.2 first
author and 2.6 total peer-reviewed manuscripts. Furthermore, 86% of past pre-doctoral and 84% of past post-
doctoral ARTTS Program trainees remain in research-intensive careers or are still in training (an additional
14% and 8% respectively are in research-related careers). Thus, the program has been highly successful in
recruiting and training the next generation of transplantation scientists. The current proposal represents the
continued commitment of a team of highly productive, diverse, and actively collaborating junior and senior
investigator/mentors, with an associated group of dedicated instructors, on a strong institutional foundation of
fundamental academic excellence, to execute a unique and carefully designed training program that will
continue to attract and retain highly motivated trainees to the transplantation field, and give them the unique
tool set needed to influence the prevailing problems in the field. The ARTTS Program thus now offers an
incredibly rich environment spanning powerful murine models in transplantation and viral immunology, an
intensive translational program at the Yerkes National Primate Center, and markedly augmented opportunities
in clinical trials and human immunology. The program continues to evolve to better attract highly qualified
candidates from across the country representing a diversity of races and ethnicities, and importantly now offers
a research focus on health disparities among minority groups in transplantation, and a particular focus to
enhancing career development in women trainees. Thus, the current offering is on the cutting edge of training
in transplantation sciences, and undoubtedly will contribute to improving the future of transplantation research
and practice for diverse individuals, and optimizing both length and quality of life for transplant recipients.

Public health relevance
Project Narrative Organ transplantation is the preferred therapy for end stage organ failure of the heart, intestine, kidney, liver, lung, and endocrine pancreas, as well as an emerging option for patients with limb, face, and other composite tissue loss and the number of patients awaiting (currently >120,000), receiving (>28,000/year) and living with (~420,000) organ transplants has approximately doubled in the past decade; however, even as the number of patients requiring innovative, scientifically sound solutions to transplant-related problems markedly increases, the number of scientists entering the field has decreased in recent years. Newly energized, transplant-focused training is required to perpetuate the pattern of discovery that has propelled the field of transplantation, and these training opportunities need to be developed cognizant of the unique clinical integration and multidisciplinary scientific and practice patterns characteristic of modern transplantation. Collaborative scientists and clinicians at the Emory Transplant Center are proposing an integrative, multi-disciplinary training program in transplantation biology (Advanced Research Training in Transplantation Sciences, ARTTS) to accomplish this goal.